Delivery of Precision Acoustic Fields to Penetrating Neural Implants to Improve Longevity and Performance of the Neural Interface

This program evaluates the application of precision acoustic fields to penetrating neural implants to prevent electrode impedance rise and improve implant longevity. Problem to be solved: Chronic neural implants hold great potential for illuminating features of neural function and treating neurological disorders. Penetrating electrode arrays provide direct access to neural signals across the central and peripheral nervous system with high spatial resolution. A consistent point of failure for chronically implanted microelectrode arrays is the poor longevity and functionality of these devices, an issue that must be addressed to facilitate clinical translation of neural implant technology. One major failure mode of electrode arrays is the host tissue’s immune response (i.e., foreign body response or FBR), which can cause glial scarring and neural cell loss near electrode sites, impairing recording quality. Significant efforts have been made to minimize the brain FBR through electrode design and pharmacological treatment, but there is no optimal solution; performance variability persists for all array types. We propose a novel, innovative means of reducing the brain FBR by employing transcranial focused ultrasound, or acoustic fields. We propose that low- intensity pulsed ultrasound stimulation of neural tissue surrounding a neural implant will reduce FBR by promoting neurotrophic release and neuron health. Hypothesis. Application of localized ultrasonic fields of different acoustic parameters and treatment intervals can affect release of neurotrophic factors, and can be used to mitigate glial scarring, promote neural implant longevity, and neuron health. Aim 1 ? Design and characterize head-mounted ultrasound transducer for chronic in vivo studies. Acceptance Criteria. Acoustic stimulation is well-coupled and is thermally safe (<1°C temperature increase in tissue model). Aim 2 ? Identify ultrasonic parameters that safely stimulate acute neurotrophin release in cortical tissue below neural activation thresholds, in vivo. Acceptance Criteria. Significantly increase neurotrophin release (e.g., BDNF) with low-intensity ultrasound stimulation, as measured through cerebral fluid sampling via an implanted microdialysis probe and tissue histology, without damaging neural tissue. Aim 3 ? Evaluate effects of low-intensity ultrasound stimulation on long-term neural electrode performance and glial scarring in cortical tissue in in vivo. Acceptance Criteria. Significantly (α=0.05) reduce the change in electrode impedance as compared to control animals (no acoustic stimulation and improve neural recording quality (number of neural units, signal-to-noise ratios), over a 4-week period. Aim 4 ? Evaluate the effects of low-intensity ultrasound stimulation on the microglia response to a neural implant in vivo. Acceptance Criteria: Significant reduction in microglia activation and migration within 200 µm of the electrode-tissue interface with periodic low-intensity ultrasound stimulation over a 4-week period.

Public health relevance
Project Narrative: Relevance – Penetrating electrode arrays can provide direct access to neural signals across the central and peripheral nervous system with high spatial resolution. Chronic electrode implants could revolutionize treatment for a range of medical conditions, including prosthetic motor control for amputees, and brain- machine interfacing for paraplegics. Unfortunately, device implantation causes an immune response that contributes to device failure over time. This project evaluates using acoustic fields to mitigate the effects that cause electrodes to fail over time.